UC Davis StARR Training Program in Veterinary and Human Health

PROJECT SUMMARY
The UC Davis (UCD) Stimulating Access to Research in Residency (StARR) Training Program in human and
veterinary medicine will recruit outstanding residents with diverse backgrounds who have demonstrated keen
interest and potential in pursuing a career as clinician-scientists. The program will include two postdoctoral
Internal Medicine MD/DO residents and two postdoctoral DVM residents and will offer a formal Master’s in
Clinical Research Training Program (MCRTP) supported by matching funds from the deans of the UCD School
of Medicine and School of Veterinary Medicine. This is a special arrangement as there are currently no other
StARR programs that cross-train medical and veterinary residents. UCD attracts an outstanding resident pool
from both disciplines as potential candidates for the StARR program. Aim 1 will select the most suitable trainees
through an extensive recruitment and competitive application process drawing applicants from both professional
schools while promoting diversity and inclusion in research training in an intentional manner. Personalized
research mentoring committees will be established to help achieve program goals, evaluate progress, and track
scholar’s Individual Development Plans. We will train ten scholars during the first grant cycle. Aim 2 will perform
a rigorous training that will propel trainees to successful research-intensive fellowships and subsequent
independence as clinician-scientists. Residents will complete a mentored research project in a specific area
supported by their mentoring committees with emphasis on the concepts of comparative medicine and One
Health, basic and translational cardiopulmonary research methods, research communication, grant and
manuscript writing, rigor and reproducibility in science, and team science. Faculty preceptors will direct research
training in three primary areas: 1) Cardiopulmonary biology and molecular medicine, 2) Emerging infectious
diseases and host responses, and 3) Data Sciences and Engineering in Translational Research. Aim 3 will
enhance training and individual career development opportunities through advanced training in a Clinical
Research Certificate program or an optional Master of Advanced Studies in Clinical Research program already
attended by SOM and SVM junior faculty. Graduated StARR alumni will continue their engagement with the
program as mentors to promote a sustained culture of resident research on their path to becoming clinician-
scientists and academic leaders. Residents will be evaluated by competency-based milestones. Program metrics
of success will include a) Scholarly productivity (publications, presentations), b) Diversity of trainees, c)
Acceptance of residents into research-intensive fellowships or academic faculty positions, and d) Future T32, K
and R grants. The existing highly collaborative environment between the Schools of Medicine and Veterinary
Medicine will provide the UCD StARR resident investigators with a creative and lively training and scientific milieu
to help them become members of high-level translational science teams and successful clinician-scientist.

Public health relevance
PROJECT NARRATIVE The UC Davis Stimulating Access to Research in Residency (StARR) is a unique StARR program as it incorporates research training for medicine and veterinary medicine residents during their critical formative academic periods. The UCD StARR program will be an institutional resource providing structured research training pathways that align with the needs of individual trainees, while addressing the need to grow academic clinician-scientists and a translational science workforce. The program takes advantage of rich mentoring interactions between the UCD Schools of Medicine and Veterinary Medicine that will mentor two MD/DO and two DVM postdoctoral residents with a goal of enabling the next generation of transdisciplinary clinician- scientists.